Machine Learning Prediction of 1-Year Mortality and Recurrence after Ischemic Stroke Using Enriched EHR data

Machine Learning Prediction of 1-Year Mortality and Recurrence after Ischemic Stroke Using
Enriched EHR data
PROJECT SUMMARY / ABSTRACT
Stroke is the leading cause of death and disability worldwide. It has been estimated that the 1-year risk of
death and recurrence after a stroke is around 15% and 10%, respectively. Furthermore, a recent report from the
Global Burden of Diseases (GBD) has shown a substantial increase in the annual number of strokes and
secondary deaths, especially in low-income groups. Recurrent strokes, with an increasing trend, have a higher
rate of death and disability. Thus, it is imperative to identify at-risk patients for recurrence and death for proper
and timely evaluation, resource allocation, and targeted prevention. The investigators’ recently published review
indicates that ─the multiple clinical scores developed for predicting stroke recurrence have only limited clinical
utility. Similarly, current stroke prognostic models vary widely in quality; prediction models of post-stroke mortality
are limited by their validation cohort size, breadth of clinical variables, and overall usefulness. The investigators
have recently developed machine learning-based models of post-stroke all-cause mortality and recurrence using
electronic health records (EHR) data. Despite promising results, our current pilot predictive models are limited
to a single health system and may have inadequate generalizability due to implicit bias.
This proposal seeks to expand and improve predictive models through the creative use of vetted EHR data
for ischemic stroke patients from three large and different health systems (Penn State Health, Geisinger, and
Johns Hopkins), caring for more than eight million people in rural and urban areas. This project will further explore
the predictive value of social determinants of health (SDoH) when added to the clinical data. The investigators
propose an integrative approach to design parameter-optimized and interpretable models, leveraging enriched
EHR to identify the risk of ischemic stroke recurrence and all-cause mortality. Aim 1: Standardize EHR-based
data across health care centers to identify clusters of ischemic stroke patients with common traits. Aim
2: Develop optimal interpretable ensemble models to predict 1-year mortality and recurrence after an ischemic
stroke. Aim 3: Validate, prospectively and externally, ensemble models for 1-year mortality and stroke
recurrence.
This proposal includes model development with internal, external, and temporal validation and lays the
foundation for an impact study to provide evidence of clinical utility. The investigators envision that this study will
lead to EHR-based screening tools that can flag high-risk stroke patients for more targeted secondary prevention.

Public health relevance
Public Health Relevance This R01 application seeks to develop and prospectively and externally validate ensemble machine-learning- based models to predict recurrence and all-cause mortality after an ischemic stroke as a promising novel approach for risk stratification for targeted prevention. The investigators will use data from three large healthcare systems to advance the manner in which large integrated datasets that are readily available in electronic health records can be leveraged for disease management and potentially improve outcomes for stroke patients. Novel findings derived from this project can be readily adapted to other complex conditions.